IGF::OT::IGF A STABLE, TIGHTLY CONTROLLED, CHARACTERIZED, DATA-LOGGING ELECTRONIC NICOTINE DELIVERY SYSTEM POP: 9/15/2015-5/14/2016, N43DA-15-8925, BASE AWARD

Evolv, Inc., the undisputed leader in advanced e-cigarette technology, proposes a research e-cigarette with sufficient control electronics and sensors to be characterized for real-world user behaviors and settings in addition to rigid laboratory conditions.